Controlled Release Eczema Bandage (CREB)

Project Summary/Abstract:
CFD Research Corporation has developed a novel microbiome-balancing wet wrap
therapy for atopic dermatitis based on a natural compound with unique physicochemical and
pharmacological activities. The compound has been found to have an interleukin-based immune
modulatory effect that helps soothe the flare-up of eczema, and it is highly selective to the
pathogen Staphylococcus aureus while being gentle to the skin microbiome, including beneficial
bacteria such as Roseomonas mucosa and Corynebacterium tuberculostearicum.
The compound was incorporated into cellulose-based fabrics such as rayon and cotton to
create a controlled-release wet wrap/bandage which will be tested on mouse models of eczema.
The technology has the potential become a standard of care for treating eczema patients and
decrease or eliminate the use of steroid ointments in controlling atopic dermatitis in children and
adult populations.

Public health relevance
Project Narrative: This project aims to develop controlled-release skin microbiome-balancing antimicrobial cotton fabrics to use as bandages and wet wraps in the treatment of atopic dermatitis and eczema infections.